The mitochondrial aspects of health disparity of hepatocellular carcinoma in Hispanic population

Hepatocellular carcinoma (HCC) is one of the fastest-rising causes of cancer-related mortality in the United
States. The biggest risk factor for developing HCC is viral infection (HBV and HCV). Other factors include non-
alcoholic fatty liver disease (NAFLD), alcohol use, and obesity/metabolic syndromes. Genetics also plays an
important role in the development and progression of HCC. Notably, HCC burden is disproportionately
expressed among different ethnic groups; the incidence and mortality rates are much higher in Hispanics than
in non-Hispanic whites (NHW) for both genders, particularly in South Texas where Hispanics are the fastest-
growing population. Moreover, Hispanics with Hepatitis C Virus (HCV) infection are at a signiﬁcantly higher risk
of developing cirrhosis and HCC compared to NHW with HCV. One major target of HCV proteins is the
mitochondria. Mitochondrial DNA (mtDNA) alterations and mitochondrial dysfunction are implicated in various
types of cancer, including HCC. A human mtDNA haplogroup is defined by unique sets of mtDNA
polymorphisms, reflecting mutations accumulated by a discrete lineage. The distribution of mitochondrial
haplogroups in the Hispanic population differs greatly from that of the NHW population, which may have some
influcence on the higher incidence of HCC in Hispanics. Based on these facts and our previous studies, we
seek to determine whether and how distinct mitochondrial haplogroups, mitochondrial dysfunction, and HCV
infection (as well as the interactions between these factors) impact HCC tumorigenesis and progresion. The
hypothesis tested here is that (1) Hispanic-specific mitochondrial haplogroup(s) and possible associated
reduced OXPHOS provide a mitochondrial background that favors HCC progresion and (2) that the
interactions between HCV proteins and mitochondrial machinery compromise OXPHOS and critical aspects of
mitochondrial pathways, leading to HCC tumorigenesis. Our recent breakthroughs include the following: (1) the
establishment of Hispanic HCC cell lines and (2) the generation of an inducible, dosage-dependent, non-
mitochondrial-conflicting expression system, which will enable us to test the overarching hypothesis. We will
generate cybrids with a Hispanic HCC nuclear background but different mitochondrial haplogroups and
investigate mitochondrial function and tumorigenesis in these cybrids. We will also test the hypotheses that (1)
reduced mitochondrial function increases HCC tumorigenesis while enhanced OXPHOS activity will decrease
HCC tumorigenesis and (2) a Hispanic-specific background will sensitize the cells to HCV-mediated HCC
tumorigenesis. Finally, taking advantage of big data about HCC patients in public databases and our unique
access to our institute’s large liver Biobank with Hispanic HCC patient samples, we will complement these
molecular investigations with bioinformatics and human epidemiology studies to verify associations between
mitochondrial genetics, mitochondrial function, and HCV infection in the development and progression of HCC
in the Hispanic population.

Public health relevance
In the United States, HCC is one of the fastest growing causes of cancer related death with a 5- year survival of less than 12%. Notably, this disease burden is disproportionately expressed among different demographic ethnic groups as the incidence and mortality rates in the US are about three times as high in Hispanics as in non-Hispanic whites in both genders. Our research is expected to generate a mechanistic linkage among the mitochondrial genotype, HCV infection, mitochondrial function and tumorigenesis in HCC, a disease that is over-represented in the Hispanic population.